Targeting Go and Grow in Glioblastoma

PROJECT DESCRIPTION
The ability of glioblastomas to proliferate in an uncontrollable manner and disperse widely within normal brain
define the malignant phenotype and make this disease uniformly lethal. Effectively treating glioblastoma
therefore requires finding targets that drive these two components of the malignant phenotype. We have
identified one such target—the myosin II family of molecular motors. We show that myosin II family members
can be targeted with a non-toxic small molecule inhibitor that is CNS permeant, and that this drug suppresses
tumor progression and significantly prolongs survival in murine models of glioblastoma. However, we also find
that targeting myosin II family members leads to a compensatory upregulation of a variety of proliferation-
stimulating signaling pathways, and that inhibiting these pathways is synthetically lethal when myosin II function
is blocked. In this proposal, we will develop strategies to enhance the efficacy of a myosin II targeting strategy
in treating glioblastoma that build on our novel findings. Results from these translational studies will be vital to
our ongoing efforts to develop effective treatment approaches that block both glioblastoma invasion and
proliferation.

Public health relevance
NARRATIVE The ability of glioblastoma to invade brain and proliferate uncontrollably makes this tumor uniformly lethal, and this highlights the need to develop new methods to block both of these components of the malignant phenotype. In this application, we propose that non muscle myosin II represents such a target, and we will investigate how to optimize therapeutic approaches that synergize with its inhibition.